Spatial organization of phenotypically diverse cells during collective migration

PROJECT SUMMARY
Cells within populations act collectively, allowing them to behave in ways that exceed the capability of a single
cell. At the same time, even a genetically homogenous population exhibits phenotypic diversity, allowing the
population to adapt in unpredictable environments. Both of these features complicate treatment of cancer,
infections, and diseases. It is of critical importance to understand how phenotypic diversity modulates a
population’s behaviors, yet this interaction is not fully understood. The proposed project will address this
knowledge gap by studying the collective migration of commensal and pathogenic bacteria. Groups of bacteria
(and eukaryotic cells) can migrate collectively by consuming attractants in the environment and chasing the
moving gradient that they have created. This allows cell populations to travel over much longer distances than
what can be achieved by an individual cell following external gradients. Our lab found that bacterial cells within
migrating groups spatially organize themselves by their chemotaxis abilities, or the speeds at which they climb
chemical gradients. This spatial organization within the migrating group allows cells with diverse motility
behaviors to migrate together because it places high performers at the front, where the traveling gradient is
shallower, and low performers near the back, where the traveling gradient is steeper. Here, I will examine the
consequences of this spatial organization for populations that are migrating in different environments and
performing pathogenesis. Aim 1 will determine how the spatial organization of motility behaviors in a
bacterial population is altered when the physical properties of the environment are changed. Then, Aim
2 will explore to what extent a population of a human pathogen utilizes the spatial organization of
secondary messenger levels and motility behaviors to co-sort virulence phenotypes. Our findings will be
used to develop a mathematical model that describes how a migrating group of cells alters the spatial
organization of its phenotypes to migrate across different environments. They will also provide insights on how
the spatial organization of swimming behaviors can lead to co-organization of secondary messenger levels and
virulence traits, allowing pathogens to perform multiple infection-related tasks simultaneously during migration.
Because some of the basic mechanisms involved – e.g. phenotypic diversity in motility and the degradation or
consumption of an external attractant to drive the collective behavior – are also present during the collective
migration of immune cells and cancer cells, the findings in the project will be relevant beyond microbiology.

Public health relevance
PROJECT NARRATIVE Phenotypic diversity allows pathogenic microbes and cancer cells to survive drug treatments and form permanent drug-resistance mutations, which poses a major challenge in medicine. It is not fully understood how phenotypic diversity contributes to collective biological functions, such as in biofilm formation and cancer metastasis. This project aims to address this general question by investigating bacterial collective migration, exploring how the diversity of phenotypes enables groups of bacteria to adapt across various physical environments and mediate pathogenesis.